Developmental Core

PROJECT SUMMARY
The goal of the Developmental Core is to develop the next generation of HIV researchers in Washington, DC in
support of the DC CFAR mission to end the HIV epidemic and to improve the health and quality of life in
persons with HIV in DC and beyond. The Core is led by a multi-institutional team of senior HIV investigators:
Drs. Michael Bukrinsky (George Washington University), Anthony Wutoh (Howard University), Kim
Blankenship (American University), Mark Burke (Howard University) and Natella Rakhmanina (Children’s
National Hospital). This leadership team covers the spectrum of DC CFAR research from basic to clinical to
social and behavioral science, with focused expertise in virology, immunology, pharmacology, physiology,
adolescent medicine and sociology. Since 2015, the Developmental Core has reviewed 147 research award
applications and funded 69 for $3.2M. Completed traditional pilot awards projects for $3.0M granted from
2010-2020 have resulted in $29.3M in new NIH grants, representing an 881% return on investment, and
$31.2M or 944% including supplements.
The Specific Aims of the Core are to: 1) lead an array of pilot award programs for early stage, new and
transitioning HIV investigators in Washington, DC; 2) implement dynamic mentoring and training programs that
support the career progression of HIV investigators; and 3) provide educational and networking activities that
promote multidisciplinary and multi-institutional collaboration in HIV research. Pilot award programs include
traditional pilot awards for early stage and new investigators, transitioning investigator awards for NIH-funded
researchers in other areas to pivot to HIV research, academic-community partnership awards, rapid response
award for emerging infectious diseases, and microgrants. The Core also provides mentoring, educational, and
training programs that complement the awards programs by providing comprehensive support to DC-based
HIV researchers. These include grant writing workshops, mentoring workshops, specific aims reviews, journal
club webinars, networking opportunities, research in progress seminars and the No Investigator Left Behind
Program to support investigators on their pilot awards resubmissions.